Core B: Data and Research Methods

Project Summary
Despite their public health significance, interventions focusing on opioid use disorder and overdose prevention
often suffer from a lack of rigorous design and evaluation. The Data and Research Methods (DRM) Core will
support COBRE Project Leaders and pilot investigators in overcoming the methodological, analytical, and
translational challenges that have traditionally stymied research project success and public health impact. By
providing quantitative expertise, research infrastructure, and technological resources, the DRM Core will
strengthen the quality of the work produced by COBRE Project Leaders, and enhance their data
use/management capacity. DRM Core services will include: 1) methodological consultation on study design
issues such as sampling, matching, survey development, and data harmonization; 2) statistical support, such
as the use of statistical models, model-building procedures, model specification, and methods to handle
missing data; 3) “dashboarding” and other visualization services to generate user-friendly, interactive data
outputs for dissemination and translation of information; 4) providing a HIPAA-compliant data management
system which will provide multi-tier access, back-ups, and de-identification; 5) providing access and linkage to
existing and new statewide overdose-related databases, as well as record matching services to enrich
outcomes across projects; and 6) providing training on and facilitating the exchange of methodological,
computational, and analytic ideas related to the study of overdose and opioid-related harms.
DRM Core Director Dr. Brandon Marshall is an established CDC- and NIH-funded investigator with extensive
experience in cohort study design, survey development, and the use of advanced quantitative methods,
including simulation approaches, to evaluate non-randomized public health interventions. His leadership will be
supplemented by highly trained staff with expertise in epidemiological methods, project management, database
development, programming, data visualization, and biostatistics.